Understanding Cardiac Mitochondrial Quality Control Through the Lens of Barth Syndrome

Project Summary
Robust mitochondrial quality control via mitophagy is necessary in cardiomyocytes (CMs) to maintain the
efficient energy production needed for contraction, calcium regulation, substrate production and response to
stress. As such, CMs utilize a repertoire of canonical and non-canonical mitophagy responses to ensure
mitochondrial quality and function. Unsurprisingly, malfunctioning, hypoactive and hyperactive mitophagy
contribute to cardiac pathologies from fetal development through adulthood. We propose to study the effects of
impairments of canonical mitophagy in the heart in the setting of TAFAZZIN (TAZ) deficiency. TAZ deficiency
underlies the X-linked disorder, Barth Syndrome (BTHS), which is a multisystem disorder with a cardiac
phenotype of left ventricular noncompaction, early-onset cardiac dysfunction, and a lifelong risk of acute cardiac
decompensation. BTHS represents a uniquely relevant platform to study the role of mitophagy in the heart
because interaction between cardiolipin (CL), the defective molecule in BTHS, and LC3, a central mediator of
canonical mitophagy, is required for at least some forms of canonical mitophagy.
In our preliminary studies we developed iPSC-derived TAZ-deficient cardiomyocytes (TAZ-KO iPSC-CMs)
and TAZ-KO mice. We found that TAZ-KO iPSC-CMs present with abnormal mitochondrial morphology and
impairments of canonical mitophagy, indicated by abnormal expression of mitophagy-associated genes and
altered response to mitophagy triggers. In TAZ-KO mice, we found mitophagy to be implicated in the severity of
cardiomyopathy. Therefore, our central hypothesis is: Dysregulation of canonical mitophagy is of fundamental
importance to the pathogenesis of dysfunction of the TAZ-deficient heart. This defective mitophagy ultimately
causes abnormal CM differentiation, response to stress, and bioenergetic capacity, all of which are characteristic
cardiac phenotypes in BTHS.
We will investigate the following questions using 2 complementary models, TAZ-iPSC CMs and the TAZ-KO
mouse via the following aims: 1) To evaluate the effect of TAZ deficiency on mechanisms of mitochondrial quality
control; 2) To determine effects of TAZ deficiency on canonical mitophagy in CM development and maturation;
3) To study differences in mitophagy and heart function between TAZ-KO mice in two different genetic
backgrounds with divergent cardiac phenotypes to understand targets for mitophagy modification.
Understanding the role of impairments to canonical mitophagy in BTHS will provide insights into mechanisms
of mitochondrial quality control in the heart, show how disrupted mitophagy affects cardiomyocyte bioenergetics
and homeostasis, and elucidate the underlying pathogenesis of Barth Syndrome.

Public health relevance
Narrative Mitochondria are organelles that function as cellular power houses, and in heart muscle cells, mitochondrial energy production is particularly important to ensure continuous, efficient heart muscle pumping. Barth syndrome is a rare disease of mitochondria that results in impaired mitochondrial quality and causes heart disease. We will investigate mechanisms for mitochondrial quality control that are affected in Barth syndrome and how they influence heart function, thereby gaining insight into fundamental mitochondrial biology that can be exploited for the generation of novel therapeutic strategies.